Pathogenic role of novel exosomal protein PRR7 in AD-associated synapse degeneration

Project Summary
Alzheimer’s disease (AD) is a progressive neurodegenerative dementia characterized by decline in memory
and cognitive function. Currently there is no effective therapeutic intervention for AD. Synapse loss is one of
the invariable pathological features and precedes AD symptom development. Considering that synapses
function as fundamental units for information storage in the brain, synapse loss is highly likely to be
responsible for the initial memory loss and cognitive decline in AD. Therefore, the prevention of synapse loss
and/or restoration of synapse numbers may help improve memory and cognitive function of AD patients. The
long term goal is to understand the molecular bases of synapse loss in AD to help develop new therapeutic
strategies. Amyloid  (A), a key molecule widely believed to underlie the pathophysiology of AD, is thought to
be the main driver for the degeneration and loss of synapses and tau pathology. However, detailed molecular
mechanisms by which A elicits synapse loss are not fully understood. Wnt signaling plays an essential role in
the formation and maintenance of synapses in the adult brain. Genetic and pathological evidence indicates that
dysfunctional Wnt signaling is associated with AD and synapse loss. Proline-rich 7 (PRR7) is a newly identified
Wnt inhibitor promoting the weakening and elimination of excitatory synapses. Aberrant expression of PRR7 is
implicated in dementia and AD. However, no studies have been performed on the pathogenic role of PRR7 in
dementia and AD. Remarkably, we found that central neurons secrete PRR7 to extracellular space via
exosomes. PRR7-containing exosomes are subsequently absorbed by surrounding neurons and induces
synapse loss in recipient neurons. Therefore, PRR7 has a potential ability to spread synapse loss in the brain
under the conditions associated with AD. The central hypothesis of this project is that PRR7 is a critical
mediator of the A-induced synapse degeneration in AD. This hypothesis has been formulated based on these
findings and preliminary data showing that soluble oligomers of Ainduce the secretion of PRR7 on
exosomes. In this project, the involvement of PRR7 in AD-associated synapse loss will be explored by using
biochemical, cell biological, and genetic approaches. First, the requirement of PRR7 in A-induced excitatory
synapses loss will be studied using cultured hippocampal neurons and an AD mouse model. Second, the role
of PRR7-containing exosomes in the spread of synapse degeneration in local neurons will be investigated. The
outcome of this research will advance our understanding of the pathogenic synapse loss mechanisms in AD
and help design new therapeutic strategy for AD.

Public health relevance
Project Narrative The proposed research is highly relevant to public health because it helps understand molecular mechanisms associated with synapse loss in Alzheimer’s disease. Moreover, the knowledge obtained from this project may provide a new therapeutic target for the treatment of Alzheimer’s disease. Therefore, the proposed research is also relevant to the part of NIH’s mission related to developing fundamental knowledge about diseases for reducing burdens of human disability.